ENERGY BALANCE, BLOOD LIPIDS DURING FEEDINGS OF DIETARY FATS

This study compares the effects of three different types of dietary fat on energy expenditure and substrate oxidation. The fats of (long chain triglycerides, medium chain triglycerides and behenic-medium chain triglyceride) are incorporated into a mixed diet for 7 days each. Energy expenditure and substrate oxidation rates are calculated from indirect calorimetry.